Modulating Indoleamines to Optimize Immunity in the Setting of Mtb/HIV Co-infection

PROJECT SUMMARY
TB remains the leading cause of death in HIV-infected persons, with one in four deaths attributable to TB. While
the majority of healthy individuals infected with Mycobacterium tuberculosis (Mtb) control infection, co-infection
with HIV increases the risk of progressing to TB disease by over 20 fold. Antiretroviral therapy (ART) decreases
the incidence of ATB and remains the cornerstone of HIV care. However, the incidence of TB in HIV-co-infected
individuals remains four-to-seven-fold higher after ART than in HIV-uninfected people in TB-endemic settings,
regardless of the duration of ART or attainment of high CD4+ T cell counts. We have developed macaque models
of Mtb/HIV co-infection which utilize ART. Depending on the timing of ART-intervention, SIV replication in the
periphery as well as tissues is either effectively inhibited or not, recapitulating the whole spectrum of human
tissue-specific and clinical outcomes. This allows for detailed longitudinal and mechanistic studies that are not
possible in humans. Our data shows a clear role for indole 2,3, dioxygenase (IDO) in both the inhibition of
effective immunity to TB as well as in orchestrating chronic immune activation in SIV-infected macaques.
Blockade of IDO pathway improves the outcome of TB and HIV in singly infected macaques. Here, we will use
inhibition approaches in the RM models of Mtb/SIV/ART to test the hypothesis that this will improve anti-TB
immune responses, inhibit HIV-induced chronic immune activation, thus allowing the immune system to better
control the co-infection. Our proposed studies will provide unprecedented novel insights into the molecular
mechanisms that mediate reactivation of TB in the setting of HIV infection, and identify protective immune
mechanisms that will inform the development of new treatment regimens and vaccines for TB.

Public health relevance
PROJECT NARRATIVE Co-infection with Human Immunodeficiency Virus (4) and tuberculosis (TB) causes extensive mortality. Identifying the molecular mechanisms that drive progression to TB disease following HIV co-infection is critical for developing improved treatment strategies. Using our well-established and faithful nonhuman primate model, we propose to test our hypothesis that both TB as well as HIV infection result in the expression of deleterious pathways /production of deleterious metabolites for immunity, and that blocking these pathways can prevent disease progression.